AGE AND GROWTH HORMONE PULSATILITY--RESPONSE TO HGRF-40 IN NORMAL MEN

Study will address the issue of defining the effect of age on the pulsatile release of growth hormone and on the response of hGRF-40 in normal man.